Project 3: From Networks and Structures to Hierarchical Whole­ Cell Models of Cancer

CCMI v2.0
Project 3: From Networks and Structures to Hierarchical Whole-Cell Models of Cancer
Project Leads: Trey Ideker and Andrej Sali; Co-Investigators: Emma Lundberg, Jennifer Grandis, J. Silvio
Gutkind, and Laura van ’t Veer
SUMMARY
One of the striking discoveries of the cancer genome projects is that each tumor presents a unique set of genetic
mutations and molecular alterations. To understand how these alterations give rise to cancer and treatment
outcomes, the Cancer Cell Map Initiative (CCMI) has launched systematic efforts to map the physical and
functional architecture of tumor cells, capturing the molecular components and pathways on which cancer
mutations converge. While parts of this effort are experimental, this Project 3 presents the central computational
framework.
A first computational theme concerns methods to assemble the structure of the multiscale tumor cell map. Aim
1 focuses on creating 3D models of cancer-associated protein complexes. It will apply established methods of
integrative structural biology to data from other projects, including cryo-electron microscopy (cryo-EM), affinity
purification mass spectrometry (AP-MS), cross-linking mass spectrometry (XL-MS), and genetic interaction
datasets. Initial efforts will focus on PIK3CA-HER3 and mTOR complexes, identified in previous work by the
CCMI, then move to new protein complexes identified by our ongoing mapping activities. Aim 2 focuses on
mapping tumor cellular components at scales at and above the protein complex, extending to larger cellular
components, compartments, and organelles. It will expand on a compelling proof-of-concept for creating an
unbiased hierarchical map of human cell components by integration of AP-MS data with protein distribution data
from immunofluorescence confocal images. These whole-cell maps will be analyzed to reveal specific cellular
components under mutational selection in breast, head-and-neck, and lung cancers.
A second computational theme concerns methods to integrate tumor cell maps with functional analysis and
predictive medicine. Aim 3 uses the maps to build interpretable deep learning systems for prediction of drug
responses. This aim draws from our previous work to establish “visible” learning models (DCell and DrugCell),
which are not black boxes but have internal organization determined by prior knowledge of biological structure.
We will construct such models from CCMI tumor cell maps, incorporating key improvements over our first-
generation pilots. Finally, Aim 4 will use visible deep learning systems alongside other machine learning models
to design and evaluate combinatorial biomarkers for breast, head-and-neck, and lung tumors in the patient-
derived xenograft (PDX) and clinical settings. Clinical samples and data will be drawn from molecular
tumor boards and the I-SPY breast cancer trial. PDX and clinical data will be used for further optimization
of our predictive models using nascent techniques from transfer learning.
Through these aims, we will advance our basic knowledge of the structure and function of tumors while
embedding this knowledge within intelligent systems for precision medicine.